Regulation of brain vascular endothelial cell ferroptosis by hyaluronan

PROJECT SUMMARY
This project is focused on understanding the mechanisms underlying brain vascular endothelial cell (BVEC)
disruption following vascular brain injury (VBI). Vascular contributions to cognitive impairment and dementia
(VCID) are the second leading cause of dementia, caused in part by VBI and blood-brain barrier dysfunction.
VBI can cause the degeneration of BVECs, leading to brain capillary leakages that promote neuroinflammation
and neurodegenerative disease. Accumulating evidence supports a role for ferroptosis, a form of programmed
cell death involving iron overload and reactive oxygen species (ROS)-dependent lipid peroxide accumulation, in
the degeneration of BVECs. A recent study suggested that ferroptosis can be inhibited following traumatic brain
injury by the glycosaminoglycan hyaluronan (HA). We find that BVECs express elevated levels of the Cell
Migration and Hyaluronan Binding Protein (CEMIP), a hyaluronidase, in patients with VBI. Elevated CEMIP
expression is accompanied by increased HA synthesis and expression of the CD44 transmembrane HA receptor.
Based on these findings, our overarching hypothesis is that HA protects BVECs from ferroptosis through a
CD44-depedent mechanism. However, if CEMIP remains elevated, HA is digested, leading to the initiation of
BVEC ferroptosis and BBB breakdown. We will test this hypothesis in the following specific aims: (1) To test
the hypothesis that HMW HA inhibits BVEC cell ferroptosis through a CD44-dependent mechanism; (2) To test
the hypothesis that HA digestion by CEMIP increases BVEC ferroptosis; and (3) To test the hypothesis that
CEMIP inhibitors can prevent BVEC ferroptosis. These studies will provide mechanistic insights into the
pathogenesis of VCID and will determine the feasibility of targeting HA signaling and CEMIP to protect BVECs,
and possibly prevent blood-brain barrier dysfunction, following VBI.

Public health relevance
PROJECT NARRATIVE Vascular contributions to cognitive impairment and dementia (VCID) is the second leading cause of dementia in the aging population, caused in part by different forms of vascular brain injury. Increasing evidence suggests that brain vascular endothelial cells, which form the small blood vessels in the brain, die during VCID through a process called ferroptosis. This project explores the possibility of preventing ferroptosis in blood vessels by manipulating the activities of an enzyme that breaks down the matrix surrounding vascular endothelial cells.